36th International Congress of Physiological Sciences Travel Program

DESCRIPTION (provided by applicant): The International Union of Physiological Sciences (IUPS) will hold its General Assembly and the XXXVI International Congress of Physiological Sciences in Kyoto, Japan, July 27 - August 1, 2009. It is proposed that the American Physiological Society administer a travel grant program offering a limited number of travel awards to qualified scientists interested in attending the IUPS Congress. Special emphasis will be given to investigators within 15 years of receiving their doctoral degree and to women and under-represented minority scientists. The specific aims of this proposal include: 1. To promote widespread participation of young scientists with an emphasis on women and under-represented minorities, through a travel award program;2. To interest new investigators and students in pursuing research designed to understand physiological processes and traits. 3. To convene an internationally recognized interdisciplinary group of investigators to explore the rapid changes that physiology has undergone as a result of the incorporation of a variety of new tools and technologies into the discipline;and 4. To provide opportunities for the development of collaborative interactions with scientists from the United States and those working outside of the United States.

Public health relevance
RELEVANCE This project is designed to bring together physiologists, interested in the clinical and basic science aspects of the discipline, at the XXXVI International Congress of Physiological Sciences in Kyoto, Japan, July 27 - August 1, 2009. The American Physiological Society will assist in these efforts by administering a travel award program offering a limited number of travel awards to qualified scientists interested in attending the IUPS Congress. Special emphasis will be given to investigators within 15 years of receiving their doctoral degree and to women and under-represented minority scientists. The goal is to provide these scientists a forum to discuss recent developments in the physiological sciences as addressed across the various commissions of the IUPS which include: Locomotion; Circulation & Respiration; Endocrine, Reproduction & Development; Neurobiology; Secretion & Absorption; Molecular & Cellular Biology; Comparative Physiology: Evolution, Adaptation & Environment; and Genomics & Biodiversity. Additional sessions are presented under the headings of Education, Ethics, and Physiome. By providing a travel award program, the Society expects to promote the widespread participation of young scientists with an emphasis on women and under-represented minorities. It is also anticipated that participation in the IUPS Congress will serve to interest new investigators and students in pursuing research designed to understand physiological processes and traits and to explore the rapid changes that physiology has undergone as a result of the incorporation of a variety of new tools and technologies into the discipline. Based on previous experiences with international congresses, attendance at the IUPS Congress will provide opportunities for the development of collaborative interactions with scientists from the United States and those working outside of the United States.